Quantitative Characterization of Glycopeptide Isomers

Because of the pressing needs to comprehensively understand the biological attributes of glycosylation in
many critical biological functions such as the immune response, cell development, cellular
differentiation/adhesion and host-pathogen interactions, glycoproteomics continues to be a highly dynamic
research area. Moreover, aberrant glycosylation for decades has been recognized as the attribute of many
mammalian diseases, including osteoarthritis, cystic fibrosis, and cancer. The diverse biological roles of glycans
and their implications in diseases have created a demand for reliable MS-based glycoproteomic approaches,
permitting sensitive monitoring of glycoproteins in biological systems. We are proposing here three specific
aims: Aim 1. Isomeric separation and structural identification of glycopeptides by porous graphitic columns at
high temperatures coupled to post-column enzyme reactor; Aim 2. Double metabolic Stable Isotope Labeling of
Glycoproteins in Cell cultures (DSILGC); and Aim 3. Develop software tools for automated identification and
quantitation of glycopeptides. The outcome of these aims will be technologies that facilitate the unequivocal
quantitative assessment of the isomeric microheterogenieties of glycoproteins associated with biological
samples. The innovations of this proposal originate from the uniqueness of the proposed analytical methods
and software. Isomeric separation of glycopeptides on PGC at high temperatures, a highly innovative method
developed in our laboratory, permits the separation of all glycan isomers associated with protein glycosylation.
Although enzyme reactors have been demonstrated by others, they usually used for protein digestion or glycan
releasing. To our best knowledge, it is the first time a post-column reactor interfacing with MS for the
characterization of isomeric glycopeptide structures is proposed (Aim 1). The simultaneous double stable isotope
labeling of both proteins and glycans that we propose here will enable simultaneous analysis of glycomics,
proteomics, and glycoproteomics with more accurate and effective quantitation (Aim 2). From the bioinformatics
point of view, our project has several novel aspects (Aim 3). Our glycan sequencing algorithm based on HCD/CID
spectra of glycopeptides reports the whole (or partial when some fragment ions are missing in the MS/MS
spectra) topology of glycan (except linkages) instead of only the monosaccharide compositions that
abovementioned methods can elucidate. Additionally, our algorithm can potentially identify new glycan
structures, since it does not rely on previously known glycan structures. More importantly, the glycan sequencing
algorithm provides complementary information to peptide identification (e.g., from CID spectra of de-glycosylated
peptides or the ETD. The deliverables of this proposal are (i) analytical methods that are readily available,
adaptable, and affordable to quantitively characterize and separate glycopeptide isomers and (ii) open-source
software that allows automated interpretation, annotation, and quantitation of glycopeptide isomers derived from
biological samples. The proposed technologies are expected to enable a better understanding of the biological
attributes of glycoproteins in the development and progression of esophagus, breast and liver cancers.

Public health relevance
The main aim of the proposed research is the development of an enabling technology that facilitates automated, efficient, and comprehensive characterization of glycopeptide isomers by LC-MS/MS. This will be attained by developing easily accessible, adaptable, and affordable glycopeptide double metabolic labeling in conjunction with separation on porous graphitic columns (PGC) at high temperatures. These methods will facilitate unequivocal quantitative characterization of the glycosylation of proteins. The proposed research activities are also aimed at the development of open-source software, enabling automated data interpretation. The deliverables of this proposal are analytical technologies that are seamlessly adaptable by laboratories interested in defining glycan isomers associated with proteins glycosylation sites. The developed technologies will facilitate a better understanding of the biological attributes of glycan isomers involved in numerous biological processes.